REGULATION OF PULSATILE FSH SECRETION BY CONTINUOUS STEROID INFUSIONS

The influence of sex steroids on the pulsatile secretion of FSH is currently unknown. We will assess the influence of sex steroids on FSH release by steady-state steroid-hormone infusions and subsequent quantitation of pulsatile secretion of FSH in normal men.